ASU Roybal Behavioral Intervention Development (BID) Core

Abstract (The Behavioral Intervention Development [BID] Core)
Behavior and lifestyle Interventions have shown promising effects on cognition, functional status, and quality of
life (QoL) in older adults with cognitive decline (defined as subjective cognitive decline [SCD], mild cognitive
impairment [MCI], or Alzheimer’s disease and related dementias [ADRD]). However, these interventions have
not been translated to make successful real-life impacts in older adults living alone with cognitive decline,
which is attributable to multifaceted reasons such as not targeting Mechanisms of Behavior Change (MoBC)
and being excluded by clinical trials if caregivers were not available. These barriers could be overcome with
technology, e.g., artificial intelligence and wearable devices that improved intervention uptake in older adults,
including those with cognitive decline and reach health disparity-susceptible populations that are
disproportionately affected by ADRD (e.g., African and Hispanic Americans). Hence, the goal of the Arizona
State University Roybal Center for Older Adults Living Alone with Cognitive Decline (ASU Roybal) is to develop
infrastructure and conduct clinical trials of MoBC-driven, technology-enabled interventions to delay ADRD and
improve QoL in older adults living alone with cognitive decline. The goals of the BID Core are to support the
conduct of 12 clinical trials of MoBC-driven, technology-enabled interventions for behavior and lifestyle change
in older adults living alone with cognitive decline and their advancement to the next stage of the NIH’s Stage
Model. Trial Investigators will engage in clinical trials aimed at applying digital technologies to modify MoBC
and/or biological targets for behavior and lifestyle change to improve proximal and long-term outcomes. For
example, Trial 1 (Stage IB) will test the effectiveness of a virtual coaching intervention on increasing physical
activity among older adults living alone with SCD. Trial 2 (Stage 1) will test if a virtual intervention that focuses
on MoBC targets of interpersonal and social processes will result in increased ability to care for one’s physical,
emotional, and social needs and plan for care. The BID Core will be co-led by Fang Yu (senior trialist who
developed and tested iPad exergame and reminiscing interventions via Stages 0 & 1 ADRD trials) and Thomas
Parsons (leading scientist for novel technology research such as developing and testing Virtual Patient to
deliver cognitive behavioral therapy). The specific aims are to 1) ensure timely implementation and completion
of clinical trials of MoBC-driven, technology-enabled interventions in older adults living alone with cognitive
decline; and 2) assist in the development and grant submission of next-stage trials to test the effects of the
MoBC-driven, technology-enabled interventions on mechanistic, proximal, and long-term outcomes in older
adults living alone with cognitive decline. A timeline will be set up for each Trial Investigator. The BID Core is
innovative in using technology to empower older adults living alone with cognitive decline and maintain their
safety and QoL. It will enact a standard individualized process to grow a cadre of scientists and interventions
and assess common strength-based and patient-reported outcomes.